BIOLOGICAL AND CLINICAL ASSESSMENT OF DEPRESSION

To determine the role of serotonin and dopamine in depression and schizophrenia by studying serotonin uptake, imipramine binding, MAO activity and plasma homovanillic acid and serum dopamine beta-hydroxylase activity in drug-free psychiatric patients and normal volunteers.